Functional MRI to Identify High-risk CKD Phenotypes

PROJECT SUMMARY
Patients with chronic kidney disease (CKD) are at increased risks of developing cardiovascular disease,
progressing to end stage kidney disease, and dying prematurely. New strategies are needed to non-invasively
identify targets to develop new therapies. Prior studies implicate decreased kidney perfusion and resultant
chronic hypoxia in the pathogenesis of kidney fibrosis. The resulting chronic histopathologic lesions, which
include interstitial fibrosis/tubular atrophy, global glomerulosclerosis, and microvascular disease lead to CKD
progression. While chronic histopathologic lesions carry prognostic value, assessment requires a native kidney
biopsy that is not performed in patients with common forms of CKD since a kidney biopsy carries risks. Non-
invasive imaging biomarkers of chronic histopathologic lesions may enable selection of high-risk individuals to
test new therapies or serve as surrogate endpoints to assess effectiveness of targeted interventions. However,
non-invasive imaging remains underdeveloped in nephrology. Gadolinium-free kidney functional magnetic
resonance imaging (fMRI) provides non-invasive assessments of kidney fibrosis, oxygenation, and perfusion.
In prior work, our team incorporated kidney fMRI into a multicenter study and showed that kidney fMRI-derived
biomarkers of fibrosis, hypoxia, and malperfusion associated with worse kidney function, differentiated patients
with CKD from healthy volunteers, and may have prognostic value. Advancement of kidney fMRI in research
and clinical practice requires further testing in a large cohort of patients with CKD that have gold standard
assessments of histopathology. The Kidney Precision Medicine Project (KPMP) offers a unique opportunity to
fill this gap. KPMP interrogates tissue obtained from research native kidney biopsy to identify critical pathways
and targets that may ultimately lead to new therapies for patients with common forms of CKD. In preliminary
data, we piloted kidney fMRI at a KPMP Recruitment Site (n=13) and showed high intra-reader, inter-reader,
and within-participant agreement of the kidney fMRI biomarkers. In this proposal, we will perform kidney fMRI
on 420 KPMP participants with CKD recruited from 7 Recruitment Sites and perform a 2-year follow-up kidney
fMRI scan in a subset of participants (n=210). We will test the associations of kidney fMRI biomarkers with
chronic histopathologic lesions and change in kidney function over time. We will extract kidney fMRI radiomic
features to determine whether unsupervised clustering of radiomic features identifies imaging sub-phenotypes
of CKD. To externally replicate our results, we will leverage de-identified data from a multicenter observational
study of ~500 patients with diabetic kidney disease undergoing kidney fMRI in Europe. This proposal builds
upon the work of an early-stage PI and fosters an ongoing cross-disciplinary collaboration among investigators
experienced in clinical phenotyping, biomarker development and testing, and imaging. The results have the
potential to inform whether kidney fMRI biomarkers identify sub-phenotypes of CKD or serve as surrogate
markers of chronic histopathologic lesions in future drug development trials in patients with CKD.

Public health relevance
PROJECT NARRATIVE Assessment of the underlying chronic scarring of kidney tissue identifies patients with chronic kidney disease (CKD) at risk of worsening kidney function over time, but this approach requires a native kidney biopsy that carries risks. We propose to incorporate kidney functional magnetic resonance imaging (fMRI)-derived assessments of kidney fibrosis, oxygen status, and perfusion into all Recruitment Sites of the Kidney Precision Medicine Project, which enrolls patients with CKD undergoing a research native kidney biopsy. The results will generate multicenter data on the associations of kidney fMRI-derived assessments of kidney fibrosis, oxygen status, and perfusion with chronic lesions in the kidney that will advance kidney fMRI as a non-invasive tool to identify chronic scarring in the kidneys and patients with CKD at risk of adverse outcomes.